Role of Damage Response in Bone Marrow Failure in Fanconi Anemia

DESCRIPTION (Provided by Applicant): The goal of this project is to gain mechanistic understanding of the functional defects of DNA metabolism associated with Fanconi anemia (FA). FA is a highly variable genetic disorder that manifests soon after birth with progressive pancytopenia and then bone marrow failure. Children with FA can also have congenital abnormalities of skeletal and other systems, and later in the course of the disease they are at high risk of developing certain cancers. FA pathway is implicated in genome stability maintenance and specifically in supporting replication of damaged DNA during S phase of the cell cycle. However, it is not known how exactly the pathway performs this function. This is in part due to the limited availability of direct, in vivo functional assays to measure replication fork metabolism in human cells. The investigators will use a novel, quantitative, and sensitive technology, microfluidics-assisted display of stretched DNA, to determine how deficiency in FA pathway affects the ability of cells to replicate lesion-containing DNA in vivo. The investigators will first analyze cell lines established from FA patient cells, and then apply their experimental scheme to the cell type that is clinically most relevant to the etiology of FA -hematopoietic stem cells. Selective depletion of this cell type is a leading cause of mortality and morbidity associated with FA, and it can be hypothesized that this phenotype is at least in part due to the increased sensitivity of these cells to DNA damage-induced replication stress, and/or increased requirement for the FA pathway in the response to this stress. By measuring replication in vivo in FA protein-deficient and control hematopoietic stem cells on the one hand, and comparing it with FA-deficient primary fibroblasts on the other, they will be able to test this hypothesis and set the stage for further mechanistic dissection of the FA pathway function in stem cells. As a first step towards this mechanistic insight, the investigators will establish a protocol for a screen for compounds that improve replication in the presence of DNA damage in hematopoietic stem cells. PROJECT NARRATIVE: This project uses a unique tool to query molecular defects of a human bone marrow failure and cancer predisposition disorder, Fanconi anemia. The results of this work will contribute to our understanding of the etiology of this disease and potentially of other heritable genomic instability syndromes.

Public health relevance
Project Narrative The goal of this project is to gain mechanistic understanding of the functional defects of DNA metabolism associated with Fanconi anemia (FA). FA is a highly variable genetic disorder that manifests soon after birth with progressive pancytopenia and then bone marrow failure. Children with FA can also have congenital abnormalities of skeletal and other systems, and later in the course of the disease they are at high risk of developing certain cancers. FA pathway is implicated in genome stability maintenance and specifically in supporting replication of damaged DNA during S phase of the cell cycle. However, it is not known how exactly the pathway performs this function. This is in part due to the limited availability of direct, in vivo functional assays to measure replication fork metabolism in human cells. I will use a novel, quantitative and sensitive technology, microfluidics-assisted display of stretched DNA, to determine how deficiency in FA pathway affects the ability of cells to replicate damage-containing DNA in vivo. I will first analyze cell lines established from FA patient cells, and then apply my experimental scheme to the cell type that is clinically most relevant to the etiology of FA - hematopoietic stem cells. Selective depletion of this cell type is a leading cause of mortality and morbidity associated with FA, and it can be hypothesized that this phenotype is at least in part due to the increased sensitivity of these cells to DNA damage during replication, and/or increased requirement for the FA pathway in the response to this stress. By measuring replication in FA protein-deficient and control hematopoietic stem cells on the one hand, and comparing it with FA-deficient primary fibroblasts on the other, I will be able to test this hypothesis and set the stage for further mechanistic dissection of the FA pathway function in bone marrow cells. As a first step towards this mechanistic insight, I will establish a protocol for a screen for compounds that improve replication in the presence of DNA damage in hematopoietic stem cells. Relevance to public health: This project uses a unique tool to query molecular defects of a human bone marrow failure and cancer predisposition disorder, Fanconi Anemia. The results of this work will contribute to our understanding of the etiology of this disease and potentially of other heritable genomic instability syndromes.